Anti-nociceptive actions of CART II in chemotherapy-induced peripheral neuropathy

PROJECT SUMMARY
Chemotherapy-induced peripheral neuropathy (CIPN) manifests in nearly 70% of patients treated with anti-
neoplastic drugs and persists after treatment discontinuation, thereby impacting patient quality of life. The anti-
depressant duloxetine (selective inhibitor of serotonin and norepinephrine uptake) offers limited pain relief, while
long-term use of opioids for chronic pain carries safety risks. Thus, novel non-opioid analgesics are needed for
pain management in cancer patients. Our findings show that supraspinal (in the brain) delivery of cocaine and
amphetamine-regulated transcript peptide II (CART II) reverses pain-like behaviors (tactile) in male and female
mice with CIPN. Multiple behavioral outputs would provide clinical face validity and bolster translatability of a
given target, thus a comprehensive dose-evaluation of CART II anti-hyperalgesic effects during chronic pain
states of CART II in both sexes at multiple endpoints of chronic pain in both sexes is warranted. Previous studies
have uncovered broader pharmacological actions of CART II and systemic administration of a neuropeptide
likely will impose a challenge, so it is critical to determine the neurochemical signaling mechanisms of CART II
in CIPN. While the lack of a known receptor for CART II has prevented such mechanistic studies, we discovered
that Lysophosphatidic Acid Receptor 2 (LPAR2) is a high affinity receptor for CART II in the brain. We used cell-
based assays and in vivo pharmacology tools to show that supraspinal LPAR2 is necessary CART II-induced
acute analgesia. However, the role of LPAR2 in chronic pain states has not been evaluated. Our findings also
demonstrate that therapeutic doses of supraspinal CART II increase glutamate release in ventrolateral
periaqueductal gray (vlPAG) and nucleus accumbens (NAcc) in naïve mice, and previous work shows excitatory
inputs into these brain sites can relieve neuropathic pain states. However, neurotransmission during CIPN in the
vlPAG and NAcc has not been fully established. The central hypothesis in this proposal is that CART II produces
its anti-hyperalgesic effects via activation of LPAR2 and increased glutamate release. Thus, we propose to fully
examine anti-hyperalgesic actions of this signaling pathway in vlPAG and NAcc in males and females via two
independent yet interconnected aims. Aim 1 will comprehensively evaluate dose-dependent anti-hyperalgesic
effects of supraspinal CART II in 4 different behavioral output measures (tactile, cold, anxiety, depression) to
interrogate any sex differences in therapeutic potential for CIPN. Incorporation of a positive allosteric modulator
and knockout mice will reveal if LPAR2 is necessary and sufficient for the anti-hyperalgesic actions of CART II.
Aim 2 will examine CART II-mediated neurotransmission as a mechanism of action for its anti-hyperalgesic
effects in CIPN. Collectively, the expected results will address significant gaps in understanding of the
supraspinal mechanisms underlying neuropathic pain states and interrogate the CART II/LPAR2 axis as a novel
therapeutic strategy in reversing already established CIPN.

Public health relevance
Chemotherapy-induced peripheral neuropathy (CIPN) affects ~70% of cancer patients in the first month and may persist indefinitely. Pain hypersensitivity and affective disorders impair patient quality of life, underscoring the need for new treatments. This proposal evaluates the anti- nociceptive effects of cocaine and amphetamine-regulated transcript peptide II (CART II) as a potential non-opioid alterative approach for treating CIPN.